ORAL 256U87 VS ACYCLOVIR FOR RECURRENT ANO-GENITAL HERPES IN HIV INFECTION

The objective of this study is to evaluate the safety and efficacy of oral 256U87 (the prodrug of acyclovir) vs acyclovir in the treatment of recurrent ano-genital herpes in HIV infected persons (CD4 > 100). There is no placebo in this study. Efficacy variables include the length of episode, the time to lesion healing, the duration and severity of pain/discomfort, the duration of viral shedding, the proportion of patients with aborted episodes, and the proportion of patients requiring extended therapy.